Institutional Career Development Core

I. INSTITUTIONAL CAREER DEVELOPMENT CORE: Project Summary/Abstract
The overall objective of the CCaTS KL2 Institutional Career Development Core is to provide superb training to
investigators who can assume leadership roles within multidisciplinary collaborative research teams that
conduct outstanding clinical and translational science. The KL2 Program is open to individuals with a doctoral
degree in a discipline applicable to clinical and translational research and an existing appointment as Mayo
Clinic faculty or under consideration for a Mayo Clinic faculty appointment. After a rigorous selection process,
successful applicants and their mentoring team formulate a career development plan based on defined core
competencies for clinical and translational science. The plan includes appropriate didactic training; experiential
and extramural learning opportunities; and a structured, mentored translational research project. The Specific
Aims of this renewal application are to 1) recruit and support a diverse group of Scholars with outstanding
potential to lead multidisciplinary, collaborative team science; 2) provide tailored educational experiences
based on individual career development needs that include appropriate didactics, experiential activities, and a
mentored research experience; and 3) foster a community of Scholars, including partnerships with other career
development programs, both within Mayo Clinic and nationally.
Key strengths of the KL2 Program include a long history of Program graduates having success as translational
scientists, a diverse pool of faculty mentors with strong extramurally funded research programs and a record of
mentoring prior Scholars, a large and diverse candidate pool subject to a rigorous selection process, a wide
range of curricular options offered without charge, novel strategies to create a positive learning environment for
all Scholars, multiple networking and community-building opportunities, options for experiential learning, strong
institutional support for the transition to independence after Program completion, and a rigorous evaluation
program.
Although the KL2 Core has a long history of success, we have identified several opportunities for improvement
and innovation, both by crafting new initiatives and by modifying existing program elements as guided by the
results of our ongoing rigorous evaluation program. Planned enhancements include new required learning
experiences in team science, social media, sex as a biological variable, mentoring (including near-peer
cascading mentorship), the hidden curriculum, inclusion and developing a positive working environment for
staff, and acting as a visiting scholar. Equipping Scholars with skills addressing these key emerging
competencies will prepare them for success as CTS investigators.